UNIVERSITY OF MARYLAND GREENEBAUM CANCER CENTERSUPPORT GRANT

Combined active antiretroviral therapy has improved survival rates in adults living with HIV and increased the number of older individuals who experience aging-associated comorbidity challenges, including cancer. Non-AIDS defining cancer (NADC) is up to three times higher than in the HIV negative population, and yet little is known about the functional and symptomatic profiles in this growing population of patients who are also aging. We will use the cancer-specific geriatric assessment and compare function, mobility, and metabolic health between older HIV+ individuals with (cases) and without (controls) NADC and hypothesize that reduced fitness, strength, and balance as well as increased symptoms will be observed in cases compared to controls. Research is critically needed to identify if a cancer-specific geriatric assessment combined with additional measures of physical fitness, balance, strength and sarcopenia and will provide new information to guide risk reduction and potential rehabilitative strategies.

Public health relevance
1.1 Project Narrative: Overall The mission of the University of Maryland Marlene and Stewart Greenebaum Comprehensive Cancer Center (UMGCCC) is to undertake innovative basic and clinical and population research that will impact the understanding and treatment of cancer around the world and to provide state-of-the-art clinical care to cancer patients in Maryland and beyond.